MBNL1's function in myofibroblast transformation and fibrosis

DESCRIPTION (provided by applicant): Cardiac fibrosis has rapidly emerged as one of the biggest problems affecting the clinical management of heart disease to date because current treatments only delay rather than prevent fibrotic remodeling and heart failure. Fibrosis results from an unrestrained tissue repair response orchestrated predominantly by the myofibroblast. Myofibroblasts are highly specialized cells characterized by a hybrid fibroblast/smooth muscle cell phenotype, as they can contract, migrate, and secrete vast amounts of extracellular matrix. The healthy heart is normally devoid of myofibroblasts, but injury-induced alterations of the mechanical and neurohumoral environment induce fibroblasts to transform into myofibroblasts. Initially, myofibroblast function is critical to the repair process as its contractile function and matrix secretion provides structural support to the injured myocardium; however, chronic myofibroblast activity eventually causes hypertrophic scarring and cumulative fibrosis, which is not only deleterious to cardiac function but creates a highly arrhythmogenic substrate. Due to the lack of genetic tools for specifically manipulating the fibroblast in vivo, the contribution ofthe fibroblast and myofibroblast to tissue repair and fibrotic disease has not been clearly defined. This proposal features two newly developed fibroblast-specific Cre knockin mouse models for delineating the fibroblast's role in myocardial repair and fibrosis and to identify the molecular regulators of the fibroblast-dependent fibrotic response. Currently, most studies examining the regulatory networks in myofibroblast transformation have been solely focused on TGFβ signaling due to its central role in initiating myofibroblast transformation and fibrosis, providin a very limited scope of the regulatory networks driving the fibrotic process. This prompted us to perform a genome-wide screen for new molecular regulators of fibroblast to myofibroblast conversion from which we identified the gene for the RNA-binding protein muscleblind-like splicing regulator 1 (MBNL1). To date MBNL1 function has never been linked to tissue repair or fibrosis, but our preliminary data in primary fibroblasts (cardiac and MEFs) demonstrates that MBNL1 is both necessary and sufficient for inducing fibroblast to myofibroblast transformation, suggesting that MBNL1 is a primary mediator of fibrotic disease. Thus, this proposal is designed (1) to directly examine the mechanism by which injury induced changes in MBNL1's regulation of transcript abundance and alternative splicing alters the fibroblast's proteome to functionally transform into a myofibroblast and (2) to directly examine the role programmed fibroblast transformation by MBNL1 has in tissue repair and fibrotic disease. By defining the regulatory networks directing fibroblast to myofibroblast transformation this proposal will further delineate the cellular and molecular underpinnings for fibrotic disease which in turn should yield new invention points for developing targeted interventions and drug discovery as many of these molecular regulators should be amenable to pharmacologic remediation.

Public health relevance
Project Narrative Cardiac fibrosis is a disease state that causes the heart to become scarred and function poorly, and as a result it is a primary contributor to progressive heart failure and sudden death, which accounts for almost 300,000 deaths annually in the United States. A specialized contractile and secretory cell called a myofibroblast is the primary initiator of cardiac fibrosis. This proposal seeks to understand the molecular and genetic basis for the development of myofibroblasts and hence the fibrotic response in the heart. __SpecificAimsTextDelimiter__ Specific Aims Most manifestations of heart disease including both ischemic and non-ischemic cardiomyopathy are accompanied by fibrotic remodeling. In the early response to injury, mechanical stress and cytokine signaling induce fibroblasts to convert into myofibroblasts, cells that generate force and synthesize increased amounts of extracellular matrix to provide support to the injured myocardium. While this initial response is beneficial, myofibroblast persistence is thought to be causal for fibrosis and the progression to heart failure. Current clinical therapies for fibrosis have been fairly ineffective, as they only delay the onset of fibrotic disease. Improved efficacy of these treatments could benefit from addressing the molecular underpinnings of fibrosis itself. However, most studies to date have been limited by myocyte-centric or pharmacologic approaches, as the genetic tools for singularly manipulating the fibroblast in vivo have been unavailable. To address this limitation, I propose to use two newly developed fibroblast-specific inducible Cre knock-in mouse models (TCF21-MerCreMer and Periostin-MerCreMer) to define the contributions of the fibroblast to heart disease and the molecular regulators of the fibroblast-mediated disease process. The overarching objective of this proposal and my independent laboratory is to directly identify the mechanisms underlying fibrotic remodeling whereby fibroblasts are programmed to convert to myofibroblasts in response to cardiac injury. A majority of myofibroblast studies have focused heavily on the TGFb signaling pathway due to its central role in regulating myofibroblast transformation. Beyond TGFb signaling the regulatory networks driving this process are poorly defined. Therefore we conducted a genome-wide screen for novel genetic activators of myofibroblast transformation, which identified muscleblind-like splicing regulator 1 (MBNL1). MBNL1 is a highly conserved RNA-binding factor that regulates transcript splicing, localization, and abundance, which can significantly alter a cell's entire proteome to induce new and specialized cellular function. For example MBNL1 directs the key adult isoform transitions of many cardiac contractile and matrix proteins. Due to their proteomic impact RNA binding proteins including MBNL1 are emerging as vital nodal points in disease networks, exemplified by MBNL1's causative role in myotonic dystrophy. MBNL1-mediated transcriptional events have not been considered as a mechanism for regulating myofibroblast transformation and hence fibrotic disease, but our preliminary in vitro data demonstrates that MBNL1 is both necessary and sufficient for inducing fibroblast to myofibroblast transformation, suggesting that MBNL1 is a primary mediator of fibrotic disease. Thus, this proposal will examine the hypothesis that injury induced changes in RNA regulation by MBNL1 alters the fibroblast's proteome such that it functionally transforms into a myofibroblast, a cell with specialized migratory, contractile, and secretory functions that can underlie fibrosis. Aim 1: Determine the role of MBNL1 in modulating the fibroblast transcriptome. RNAseq and RNA immunoprecipitation (RIP) will be used to test the hypothesis that MBNL1 overexpression in cardiac and mouse embryonic fibroblasts (MEFs) alters the abundance or isoform type of those mRNA transcripts that underlie myofibroblast transformation. By examining two types of fibroblast we can identify if these mechanism extend to fibroblasts derived from other tissues. (1A) RNAseq has been performed on MBNL1 infected, TGFb induced, and wildtype MEFs and will be analyzed to identify which of the differentially expressed transcripts and splice variants are responsible for MBNL1-mediated myofibroblast transformation. (1B) RIP on subcellular fractions will be used to determine if those myofibroblast transcripts are directly bound and preferentially localized by MBNL1. (1C) 6-10 of the MBNL1 target genes confirmed by RIP will be the basis for mechanistic experiments in cultured fibroblasts to define their position in the transformation pathway. Aim 2. Examine the role of MBNL1 in cardiac wound healing and fibrosis in vivo through its function of transforming fibroblasts into myofibroblasts. (2A) Mice with fibroblast-specific inducible expression of MBNL1 will be used to test the hypothesis that fibroblast-specific MBNL1 overexpression will induce myofibroblast transformation and hence cardiac fibrosis. (2B) MBNL1 knockout mice will be used to test the hypothesis that MBNL1 expression in fibroblasts is required for myofibroblast transformation and the wound healing response to myocardial infarction. Aim 3: Examine the relationship between MBNL1 and TGFb mediating myofibroblast transformation and cardiac fibrosis. (3A) An in vitro reductionist approach in fibroblasts will be used to test the hypothesis that MBNL1 is regulated by non-canonical TGFb signaling. Here the gain and loss of key TGFb signaling nodal points will be manipulated in cardiac fibroblasts and MEFs to elucidate the relationship between MBNL1 and TGFb signaling. (3B) MBNL1 knockout mice will be crossed with a cardiac-specific TGFb overexpressing transgenics (a model of cardiac fibrosis) to test the hypothesis that loss of MBNL1 function will block TGFb- mediated heart disease in vivo.